REGISTRATION, STORAGE AND DISTRIBUTION OF CHEMICALS AND DRUGS FOR PRE-CLINICAL DISCOVERY EVALUATION AND DEVELOPMENT

The Drug Synthesis and Chemistry Branch (DSCB) of the Developmental Therapeutics Program (DTP) of the Division of Cancer Treatment and Diagnosis (DCTD) of the National Cancer Institute (NCI) is seeking support services to operate and maintain the National Cancer Institute’s Chemotherapeutic Agents Repository (NCI-CAR). The principal goals of this contract is 1) to support compound acquisition activities related to the DTP anticancer pre-clinical drug evaluation program which seeks to identify new small molecule therapeutic agents and 2) distribution of chemicals to intramural and extramural investigators for research purposes. The primary tasks of the contract are the receipt, registration, storage, analysis, arraying and distribution of small molecules and purified natural products. In addition, a lesser number of compounds from other NIH (e.g. NIAID, NExT, NCATS) programs may be handled through this contract.

This contract is also responsible for providing an informational interface with NCI and external investigators that are submitting or requesting research compounds; for updating of the chemical database which includes chemical, inventory, receiving and shipping information; systematic file and record keeping of both current and archival information related to Repository activities; and reacquisition of samples for continued chemical and biological studies.

The program is highly flexible and the Contractor shall have the flexibility to respond to changing Program priorities.